Development of Computational Tools and Their Applications to Various Biological Systems

PROJECT SUMMARY
Biological macromolecules work together in a complex network to carry out essential cellular functions in living
organisms. Understanding this complex network of interactions at the molecular level by developing necessary
computational tools is an all-encompassing goal of our laboratory. This proposal aims to continue such efforts
particularly on CHARMM-GUI for the biomolecular modeling and simulation community, G-LoSA-related tools
for structural systems pharmacology, and GlycanStructure.ORG for glycan modeling and simulation and glycan
binding site prediction. First, CHARMM-GUI has become an essential web-based cyberinfrastructure for
constructing complex biomolecular simulation systems. We will further develop and expand its functionality to
support more force fields, QM/MM interface for enzymatic catalysis reactions, more advanced simulation
methods, API development, and DOI assignment. Second, we will continue to expand the application of our
local-structure centric computational toolset, G-LoSA (Graph-based Local Structure Alignment), for the studies
of protein-ligand interactions at the proteomic level. Our local structure refinement method will be extended to
include protein-protein binding interfaces to further elucidate conserved local surface regions of protein-protein
interactions that are crucial in biological processes. Third, our glycan modeling and simulation toolset will be
extended to glycan binding pose prediction, glycan binding site prediction, and glycan binding site optimization
for rational design and refinement of a known or potential glycan binding site. The successful completion of this
project is expected to provide a large and unique scope of research software tools for the biomedical research
community to carry out innovative and novel biomolecular modeling and simulation research for the prevention
and treatment of human disease.

Public health relevance
PROJECT NARRATIVE An all-encompassing goal of our laboratory is to understand the complex network of molecular interactions in various biological systems at the molecular level by developing necessary computational tools. This proposal aims to continue such efforts particularly on CHARMM-GUI for the biomolecular modeling and simulation community, G-LoSA-related tools for structural systems pharmacology, and GlycanStructure.ORG for glycan modeling and simulation and glycan binding site prediction. The proposed project is expected to provide a large and unique scope of research software tools for the biomedical research community to carry out innovative and novel biomolecular modeling and simulation research for the prevention and treatment of human disease.